Designing technologies to visualize protease activity in cancer models

PROJECT SUMMARY
Cancer is a collection of diseases that are caused by the uncontrolled proliferation of cells. It is the second
leading cause of death in the United States of America and approximately 40% of Americans will get diagnosed
with cancer at some point in their life. Proteases, which are enzymes that cleave peptide bonds, play vital roles
in many steps in cancer progression, including migration and metastasis. Drugs that target protease activity
have entered clinical trials, however they were all unsuccessful. New anti-protease therapies are being
developed with improved enzyme specificity to reduce unwanted side-effects. Thus increasing our
understanding of protease activity in the tumor microenvironment is needed to bring these promising drugs to
the clinic.
The objective of this project is to develop biomolecular conjugates which can visualize protease activity within
model tissues in order to understand how cancerous cells modulate the activity of other local cells. These
conjugates combine nucleic acids and peptide such that a protease cleaving the peptide activates the nucleic
acid for binding. This will be used quantify protease activity around individual cell types. Since nucleic acid
hybridization is sequence-specific, multiple protease can be studied simultaneously within a single hydrogel.
The conjugates will be coupled to the hydrogel using “click” chemistry. This enables the molecules to be added
during cell culture in order to study protease activity at specified time points. These conjugates have been
designed so that they can be made on automated synthesizers, and can be easily incorporated into most
biomaterials platforms.
This research plan includes two specific aims that were designed to develop protease-responsive conjugates,
incorporate them into hydrogels, and visualize spatiotemporal protease activity in a model tissue. The first aim
will develop nucleic acid-peptide conjugates which are able to bind fluorophore-labelled complementary strand
only after they been “activated” by proteases. The second aim will incorporate these conjugates into hydrogels
for simultaneous spatiotemporal visualization proteases in a hydrogels containing both cancerous and
noncancerous cells in order to better understand metastatic processes. We hypothesize that cancer cells
cultured with non-cancerous cells will have altered protease activity. This approach is powerful because it can
be easily adapted by other labs, can be used for many proteases and incorporated into most biomaterial
systems. Since proteases catalyze the cleavage of a peptide bond, they are especially useful for making
stimuli-responsive therapies. Thus this research can help researchers across disciplines develop more
effective biomedical interventions.

Public health relevance
PROJECT NARRATIVE Proteases are a class of enzyme that play important roles in many important physiological processes, including development, regeneration, and cancer progression. Quantifying the activity of proteases within tissues is challenging and the current options are limited. This proposal utilizes novel nucleic acid-peptide conjugates as protease-responsive elements which can enable spatiotemporal visualization of proteolytic activity, which will help improve our understanding of cancer progression and develop more effective regenerative therapies.